Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The mission of the Center for Chronic Disease Reduction and Equity Promotion Across Minnesota
(C2DREAM) is to support and translate innovative, transdisciplinary research that intervenes on and addresses
racism at multiple levels as a fundamental cause of disparities. Specifically, C2DREAM targets disparities in
cardiovascular disease (CVD), hypertension, and obesity, hereafter referred to as CVD and RCC (related
chronic conditions), among Black, Indigenous, and people of color (BIPOC) across a diverse rural-urban
Minnesota region. The C2DREAM Administrative (AD) Core will provide strong, equity-guided governance,
administrative, and communications infrastructure; coordinated data collection of innovative measures of
racism at multiple levels and shared implementation processes; innovative research assessing the
multifactorial relationship between structural and interpersonal, intervention efficacy, and chronic disease-
related behavior change; innovative programming that connects trainees, researchers, community
stakeholders, and policy makers in knowledge sharing and application for change; and equity-oriented rigorous
evaluation to assure center impact. The AD Core’s success will be reflected in the Center’s launch and
sustenance, and seamless integration of all Core activities and research projects. We build on extensive
institutional infrastructure, professional and community relationships, compelling health equity research, and
vibrant intellectual and translational activities across the region. The AD Core embraces a shared leadership
model—reflected throughout the Center—underscoring our belief that health equity will be achieved in
Minnesota only through collective action drawn from strong inter-institutional regional collaboration and multiple
sources of knowledge. Buttressed by strong institutional foundations and enhanced regional networks, the AD
Core will foster C2DREAM’s regional impact in several important ways: (a) Provide the infrastructure,
governance, and leadership to ensure that all C2DREAM components operate efficiently across the region. (b)
Leverage innovative means to assess racism at multiple levels. (c) Augment activities offered by other Cores
to creatively support the productivity of early-stage researchers. (d) Apply robust equity-grounded multimodal
evaluation methods to inform flexible adaptation of our approaches and ensure we achieve the Center’s goals,
and promote exportation of lessons on the most effective elements for use by other P50 centers.